1/2 GeoHealth Hub for Climate Change and Health in the Middle East and North Africa-Jordan

Abstract
The Middle East and North Africa (MENA) region is going to be at the center of climate change adverse health
impacts. Already record heatwaves, high frequency of desert dust storms, drought and low precipitation, and
high air pollution are being documented. However, studies about their health impacts on the populations are
scarce and not linked to climate change policies and there is limited multi-country efforts in the MENA Region to
address the different health effects of climate change. In our project, we aim to establish the “GeoHealth Hub for
Climate Change and Health in MENA” through two components: the U2R which represents the part related to
capacity building of stakeholders from the MENA Regions and the U01 which is the component developing the
research profile. From MENA, the Jordan University for Science and Technology, The University of Balamand,
and Mohamed VI University of Health Sciences will be partnering with the University of California San Diego,
University of California Berkeley, and Harvard University from the U.S. In addition, the U.S. CDC, and the WHO
Center for Environmental Health Action will be an integral part of the hub. The impacts of climate change on
health, water, air pollution and identified gaps and areas of development in environmental and public health will
be the initial focus of the hub. The ultimate goal is to produce and support climate change policies that protect
and promote environmental and public health and become the state-of-the-art entity to provide models and tools
for quantifying the health and economic impacts of climate change risks in relation to water scarcity, heat waves,
air pollution, and desert dust. The research project in Jordan will study the impact of two climate change-induced
public health threats: (1) water scarcity and nitrate pollution and (2) heatwaves. The spatial and temporal
downscaled climate change will be constructed to identify areas of potential vulnerability to climate change. The
spatial and temporal analysis of nitrate pollution across Jordan will be assessed. Moreover, the impact of nitrate
levels on birth weight of newborns will be documented. Furthermore, the impact of heatwaves on mortality under
the baseline climate scenario as well as under the climate ensemble model predictions will be investigated. In
Lebanon, the health impact of air pollution on respiratory, cardiovascular, and skin allergic diseases among
women and children will be studied. In Morocco, the association of desert dust air pollution with climate will be
determined using large-scale atmospheric patterns and climate indices. Seasonal weather patterns favorable to
particulate pollution partially originating from the Saharan desert will be identified. These studies build on prior
research conducted by the team members and will be followed up by policies recommendations on wastewater
reuse, heatwaves alerts, and air pollution from combustion and desert dust. Ministries of Health and Environment
from participating countries will be key partners in this project and will be involved in capacity building and training
of their relevant staff in air pollution, water quality and advanced environmental epidemiology.

Public health relevance
Project Narrative The GeoHealth Hub Climate Change and Health in the Middle East and North Africa (MENA), a collaborative initiative between three U.S. universities and three universities from the MENA Region, to generate evidence for policies to minimize adverse health impacts of climate change in the region through state-of-the-art approaches. It will focus on climate-sensitive environmental risks such as nitrate pollution, heat waves, desert dust pollution, and air pollution. The overall activities of the hub aim to strengthen the capacity of different stakeholders on developing and using evidence-based and cost-effective interventions.